X-ray/optical tomographic guidance and assessment for pre-clinical radiation Research

PROJECT SUMMARY/ABSTRACT
Our field is rich with new opportunities to refine the use of radiotherapy(RT). The integration of RT with
immunotherapy(IT) holds transformative potential for cancer treatment, yet clinical outcomes have been
unpredictable. Emerging FLASH-RT, delivering dose at ultra-high dose rates, promises to reduce healthy
tissue damage while maintaining tumor control. However, the mechanism of this protective effect is not well
understood. To bridge these knowledge gaps and promote the clinical adoption of new radiation therapies, the
development of quantitative imaging techniques is essential, which are indispensable for conducting rigorous
pre-clinical studies. Fluorescence imaging(FI) is a powerful tool for detailed exploration of tumor biology and its
response to therapies. Multiplex FI enables the tracking of multiple biological processes, including the
migration of tumor and immune cells as well as changes in tissue oxygenation, which are crucial for RT.
However, quantifying in vivo fluorescence based on intensity presents challenges. Issues such as tissue
autofluorescence, leakage of excitation light into the detection window due to a small Stokes shift of
fluorescence, and spectrally dependent tissue absorption could introduce errors in fluorescence quantification.
These errors are exacerbated when multiplexing techniques are used, as crosstalk between the emission
spectra of fluorophores can further compound inaccuracies. Building on the promising results achieved during
the Phase I period and address the aforementioned challenges, we propose significantly enhancing the
quantitative capabilities of our fluorescence imaging-guided system through the adoption of fluorescence
lifetime(FLiT) imaging. Unlike the intensity-based FI, FLiT is unaffected from autofluorescence, light leakage,
absorption and crosstalk among fluorophores. FLiT imaging offers robust quantitative data by measuring the
lifetime of fluorescence signal. It thus allows a more accurate distinction between reporters and offers higher
accuracy in quantifying fluorophore concentration compared to the intensity-based FI. FLiT imaging is highly
complementary to the bioluminescence and fluorescence tomography(BLT/FT) system developed in the Phase
I period for guiding radiation delivery and assessing treatment response. A multimodality CBCT/BLT/FLiT/FT
imaging capabilities that complements the small animal radiation research platform(SARRP) would provide a
powerful platform for pre-clinical radiation research. The development of FLiT imaging to support image-guided
radiation studies falls perfectly within the scope of the parent grant and represents a logical extension of the
original aims. Extending from the aims of Phase I proposal, the aim for the Phase II research period is to
construct a FLiT imaging system compatible with the optical system(MuriGlo) to advance the quantitative
imaging and FT-guided capabilities for the SARRP. The success of the extension will lead to a high-specificity
and quantitative in vivo fluorescence imaging system. It would advance the already promising BLT/FT-guided
system(MuriGlo), effectively tracking multiple biological processes in vivo and their response to therapies.

Public health relevance
PROJECT NARRATIVE We propose to integrate fluorescence lifetime imaging with our existing optical system to address critical challenges in radiation guidance by enabling precise quantification of biological markers, unhampered by the limitations of intensity-based fluorescence imaging. This advancement will significantly enhance pre-clinical radiation research, facilitating study reproducibility.